Administrative Core

Introduction to the Resubmitted Application- ADMINISTRATIVE CORE The only substantive comment regarding the Adminstrative Core was the request that the Core Principal Investigator, Dennis R. Voelker increase his time commitment to Administration to 5%. This change has been made in the resubmitted application.

Public health relevance
Virus induced exacerbations of asthma are responsible for high levels of patient hospitalization and emergency room visits and significant economic burden. This proposal investigates new approaches for: 1) identifying environmental causes of exacerbation, 2) predicting patients who will exacerbate using minimally invasive techniques and 3) preventing infection by human rhinoviruses, which are the chief instigators of asthma exacerbation.